CORE--MORPHOLOGY

Investigators who need to use morphological techniques frequently do not have the facilities in their own laboratories. In addition, project personnel, especially young investigators, often come to the Council without training in these techniques. The Morphology Core provides a number of avenues which enable investigators to produce high quality work involving light and electron microscopy, immunocytochemistry, in situ hybridization, and photography.